CORE--DEVELOPMENTAL FUNDS

Description: Developmental Funds are requested to assist in recruiting including start-up funds and salaries, interim support for investigators during lapses in grant funding, and pilot projects to initiate and examine new ideas as collaborative projects. In the current funding period, seven new recruits were hired using funds from this resource. Future recruiting is planned to expand and enhance most of the programs in the Cancer Center. Interim support has assisted four investigators in the last four years and each was able to obtain NIH or other peer-reviewed funding with the help of this support. Currently there is no pilot project funding in the Cancer Center budget so this addition is proposed to induce collaborations.